Preparation of Artificial Dicopper Enzymes for the Catalytic Reduction of CO2

Project Summary The successful development of artificial metalloenzymes tests our understanding of enzymatic catalysis, protein folding, and bioinorganic chemistry. A distinct and unmet challenge in this arena is the development of redox-active, artificial metalloenzymes that exhibit catalytic activity with small molecules. Nature employs a diverse array of copper-containing enzymes that make use of the tunable redox properties of this ubiquitous metal ion. This proposal outlines the design of flexible metal binding sites that accommodate two redox-active and coordinatively-unsaturated copper ions at the interface of complementary protein monomers or within a reengineered maltose binding receptor protein. These designs will be guided by computational methods, X-ray crystallography and bimetallic templating strategies. As a test for the catalytic properties of the designed site, we will investigate the CuI2- catalyzed reductive coupling of CO2 to oxalate.

Public health relevance
Project Narrative Metalloenzymes mediate many chemical transformations that are essential to life on this planet. The successful design of artificial redox-active metalloenzymes remains a significant challenge in protein design. This proposal aims to prepare artificial dicopper enzymes that catalyze the multielectron reduction of two CO2 molecules to oxalate.